The Role of Long-Range Inhibitory Neurons in Cortical Circuits

Project Summary
Cortical activity changes dramatically upon changes in behavioral state of an animal with different behavioral states, such
as sleep and wake, having profound impact on cortical processing. The circuitry responsible for sensing behavioral state
and modifying cortical activity to generate cortical states remains unknown. However, inhibitory neurons (INs) have been
recently implicated in this role. Interestingly, both dysregulation of behavioral states and disruptions in INs are hallmarks
of major neuropsychiatric disorders. Here, I propose that a specific sub type of inhibitory neuron in the cortex plays a role
in the generation of low-frequency oscillations, a hallmark of multiple cortical states. I propose that the long-range inhibitory
neurons of the cortex play a crucial role in the generation of low-frequency oscillations.
Long-range inhibitory neurons are highly distinct from other cell types in the cortex both in terms of their morphology and
gene expression. While other INs in the cortex project locally, long-range inhibitory neurons project across many
millimeters, in the mouse, and across cortical areas. Previous studies of the connectivity of these cells have been hampered
by the necessity to slice tissue and fill cells to generate morphologies limiting our knowledge of these cells. In my first aim,
I plan to address these issues using tissue clearing and light sheet microscopy to determine the postsynaptic areas targeted
by these cells. I will compliment this with 2-photon recordings of the activity of these cells performed across behavioral
states to determine the activity patterns affecting downstream areas.
In my second aim, I will perform in vivo function characterizations of long-range inhibitory neurons using optogenetics and
electrophysiology. Ex-vivo studies suggest that long-range inhibitory neurons are active during slow wave sleep, a period
of low-frequency oscillations. I will perform in vivo extracellular electrophysiology while using optogenetic tools to
manipulate the activity of long-range inhibitory neurons. I will use excitatory opsins with frequency modulated stimulation
and an inhibitory opsin. I will measure the responses of single units and network oscillations to this stimulation. I will
perform manipulations in long-range inhibitory neurons and other neuronal types to show specificity of results testing the
hypothesis that these cells regulate the generation of low-frequency oscillations.
Together these two aims provide the first in vivo characterizations of the activity of long-range inhibitory neurons. When
completed, I will be able to relate the connectivity, morphology, and activity patterns of this cell type to understand the role
of this cell type in cortical circuits.

Public health relevance
Project Narrative The cortex is made up of two main classes of cells, excitatory pyramidal cells and inhibitory interneurons, however, there exists a cell type that is dissimilar from both. The long-range inhibitory neuron is remarkable in its unique morphology and gene expression profile, and this cell type likely plays a similarly unique role in cortical circuit function. Here, I set out to characterize this cell type and test the hypothesis that it regulates the generation of low-frequency oscillations in the cortex.